Leveraging the Gastric Submucosa as a Host for Cell Therapies

The objective of these studies is to better understand submucosal biology as it relates to implantation
of cell therapy devices. Endoscopic submucosal dissection (ESD) is employed to access the gastrointestinal
(GI) submucosa for excision of lesions, therapeutic myotomy, and even peritoneal access. Expansion of this
technique to include device implantation could enable novel approaches to long-term delivery of therapeutics,
including cell therapies, to the GI tract. However, the biology of the submucosal space as a host for
implantable devices is not well understood. The long-term goal is to leverage the GI submucosa as a host for
regenerative therapies in the treatment of degenerative or autoimmune GI pathologies. The central hypothesis
of the proposed work is that the submucosa can serve as an effective host for cell therapies. A model involving
pancreatic islet transplantation into the gastric submucosa for the treatment of type 1 diabetes (T1D) will be
employed, inspired by the finding of subepithelial heterotopic pancreatic tissue (or “pancreatic rests”)
incidentally found on biopsies of the stomach. The pancreatic islet is a compelling cell model as there are
existing animal models for T1D and validated assays to quantify islet survival and function. The rationale is that
evaluation of the gastric submucosa as a potential host for cell therapies may not only lead to breakthroughs in
the treatment of T1D, but also localized treatment of degenerative GI disorders in which normal tissue has
been compromised. The central hypothesis will be tested by pursuing 3 specific aims: 1) Evaluate endoscopic
procedure technique and safety for submucosal implantation in a swine model; 2) Characterize in vivo host
response to submucosally implanted materials and devices; and 3) Determine encapsulated islet survival and
function as well as phenotypic rescue. For Aim 1, a swine model will be used to evaluate outcomes and
complications of ESD with and without device implantation, using devices of various geometries. To achieve
Aim 2, tissue histology, immunofluorescent staining, flow cytometry, RT-PCR, and scRNA-seq will be used to
evaluate the host response to ESD/device implantation as compared to the more common methods of
subcutaneous and intraperitoneal implantation. For Aim 3, devices containing a test dose of allogeneic islets
will be implanted into the gastric submucosa to evaluate islet survival and function (using immunofluorescent
staining, RT-PCR, and scRNA-seq), and if successful, therapeutic doses will be implanted in a T1D swine
model to evaluate for phenotypic rescue. The proposed research is significant as it will demonstrate a novel
approach to GI device delivery and improve understanding of submucosal biology as it pertains to device
implantation. Ultimately, this will contribute not only to the field of T1D and cell therapies, but also offer
valuable insights for the future development of submucosally implanted localized treatment of other disorders,
including degenerative GI disorders. This project will provide unparalleled training experience to the applicant
in the translational aspects of implantable device design, large animal models, and submucosal biology.

Public health relevance
PROJECT NARRATIVE Accessing the submucosal space within the wall of the gastrointestinal tract is an attractive minimally invasive method that could be used for the implantation of therapeutic devices and cell therapies. However, the biology of the submucosal space as a host for cell therapies is not well understood, limiting development of these technologies for clinical application. This proposal aims to develop new knowledge in this area, which will be critical for subsequent potential therapeutic human applications.